Development of Sulfur-Based Reactions with Translational Applications

Project Summary/Abstract
Cross-coupling reactions provide the most reliable and modular means to diverse chemical space, enabling the
discovery of novel pharmaceuticals and elucidation of critical biological pathways. Seminal efforts spanning the
last century have led to the development of a variety of metal-catalyzed cross-coupling reactions that allow
efficient chemical bonds formation. However, these powerful chemical transformations still have shortcomings.
Endeavors in developing novel coupling methodologies could address the identified challenges in the chemical
literature. More importantly, they can be deployed to rapidly synthesize structurally and topologically complex
compounds from accessible starting materials. Our research laboratory is seeking to invent new synthetic
approaches to address this identified gap in the cross-coupling literature, specifically focusing on methodology
development with the nonmetal element sulfur, one of the most abundant and inexpensive starting materials with
versatile oxidation states (–2 to +6). We propose high valent sulfur complexes can enable diverse coupling
modes in either stoichiometric or catalytic fashions. This proposal is organized into three sections with the goal
of addressing current limitations in synthetic methodology and affording the ability to rapidly generate diverse
and complex small molecule libraries. The first portion of this proposal illustrates a plan for sulfurane-mediated
hindered C(sp2) and C(sp3) coupling via S(IV) to S(II) reduction. The second section illustrates how nonmetal
sulfur (S(VI) to S(IV)) can provide a general and practical solution to alkyl boronate synthesis, especially for
unprotected alkyl boronic acids. The last part of this proposal argues that persulfuranes have the potential to
mediate synthetically valuable C–F bond formation, even possibly in a catalytic manner (S(VI) ↔ S(IV)). These
described methods will enable facile access to scaffolds of interest for medicinal chemistry and biological
evaluation. The biological properties of several families of compounds will be further investigated through our
already established collaborations. Taken together, these innovative new synthetic modes could address the
synthesis of challenging and medicinally relevant chemical scaffolds.

Public health relevance
Project Narrative To discover novel pharmaceuticals and elucidate of critical biological pathways, there is an urgent need to invent chemical methods enabling rapid and modular access to diverse chemical space from simple starting materials. This proposal outlines new chemical transformations based on the affordable nonmetal element sulfur to strengthen our ability to access complex molecules of relevance to the pharmaceutical industry.